The autophagy core complexes in neuronal quality control

PROJECT SUMMARY
Autophagy is universal in eukaryotes as a cytoprotective mechanism for the clearance of inclusions, damaged
organelles, and other harmful materials. Autophagy has major roles in aging and neurodegeneration, including
in Parkinson's disease, Alzheimer's disease, amyotrophic lateral sclerosis (ALS), frontotemporal degeneration,
and Huntington's disease. Autophagy involves the formation of a unique cup-shaped double membrane, the
phagophore, which expands, engulfs cargo, and finally closes and fuses with lysosomes. The importance of
autophagy as a neuroprotective mechanism has motivated attempts to therapeutically enhance autophagy in
the brain. In contrast to nearly all other tissues, bulk autophagy in neurons is decoupled from amino acid
levels and mTORC1 signaling. Growing evidence points to levels of the lipid phosphatidylinositol 3-phosphate
(PI(3)P) as rate-limiting in autophagy in neurons. Our laboratory has done much of the paradigm shaping work
on the molecular, structural, and biochemical mechanisms of regulation of the class III PI 3-kinase complexes
that generate PI(3)P, positive and negative regulators of PI 3-kinase complexes, and their PI(3)P-dependent
downstream effectors in autophagy. Here, we will combine cryo-EM, structural modeling, biochemical
reconstitution, and functional assays and cell imaging in i3Neurons to determine how PI(3)P levels are
controlled, and in turn control neuronal autophagy. Assays of i3Neurons will differentiate between bulk
autophagy and different forms of mitophagy, and further differentiate between autophagy events in axons,
axonal boutons, and soma. Imaging tools will include mitoKeima and HALO-based assays and CLEM and FIB-
SEM imaging of autophagy in axons and axonal boutons in i3Neurons bearing a range of knockouts,
autophagy probes, and fluorescently tagged subunits of autophagy core complexes. We will determine how the
key lipid kinase complex of autophagy, the class III PI 3-kinase complexes I (PI3KC3-C1) is regulated by the
key autophagy-initiating ULK1 complex. We will determine the high-resolution structure of the PI3KC3-
C1:ULK1C supercomplex and analyze its function and regulation in distinct compartments within neurons.

Public health relevance
Project Narrative Autophagy is an ancient and conserved mechanism for cell survival under starvation and stress, with profound connections to neurodegenerative diseases and aging. Unlike most other cells, neurons are resistant autophagy induction through mTORC1 inactivation, yet emerging evidence suggests that levels of the lipid PI(3)P are crucial. Here, we will combine cryo-EM, structural modeling, and biochemical reconstitution with compartment-specific functional assays and cell imaging in i3Neurons to determine how PI(3)P levels are controlled by the ULK1C-PI3KC3 supercomplex, and in turn control neuronal autophagy.